DNA Base Detection Using 2D Materials Beyond Graphene

PROJECT SUMMARY/ABSTRACT
Two-dimensional (2D) materials have emerged as revolutionary materials for fast, single-nucleotide direct-read
DNA sequencing with a minimum amount of consumables. Due to its commercial availability, graphene remains
the most widely explored 2D material for DNA sequencing applications. The major hindrance of graphene is the
hydrophobic nature of its surface which causes DNA bases to stick to its surface, slowing down translocation
speed, and making single-base discrimination difficult as multiple bases interact with graphene at any given time.
Furthermore, the lack of a band gap in pristine graphene makes it undesirable for use in electronic detection
modalities. With all the disadvantages of graphene, we strongly believe that graphene will not be the ultimate
material for DNA sequencing. More promising in our view are approaches that explore the conductive properties
of various 2D materials beyond graphene. The primary goal of this research is to perform large-scale, first-
principles computational studies to evaluate various 2D materials beyond graphene for faster and affordable
DNA sequencing using electronic methods. A secondary goal is to train undergraduate and graduate students
in computational materials modeling. To accomplish our goals, we will focus on three independent, but
interrelated specific aims as outlined below: (1) DNA base detection using elemental 2D materials. In Aim 1,
we will expand on existing studies involving graphene for DNA base detection to include other elemental 2D
materials such as silicene, germanene, and phosphorene. One of the major goals of Aim 1 is the research
training of undergraduate students. (2) DNA base detection using 2D transition metal dichalcogenides
(TMDs). We will perform a comprehensive study of DNA sequencing using six of the most popular TMDs (MoS2,
WS2, MoSe2, WSe2, MoTe2, and WTe2). These materials have desirable properties such as tunable direct band
gap, excellent mobility, and they are easy to fabricate. Moreover, due to their hydrophilic nature, we anticipate
strong couplings with bases on the DNA that can enhance the tunneling currents leading to improved signal-to-
noise ratios. (3) DNA base detection using van der Waals (vdW) materials. This activity will shift the current
paradigm in DNA sequencing, because we will evaluate, for the first time, the potential of vdW heterostructures
for DNA sequencing. vdW systems formed by combining two or more single-layer 2D materials allow for a greater
number of potential sensing materials. Also, the synergetic effects produced when different materials are
combined could lead to advanced detection principles that are superior to those of the individual materials. The
impact of our research will be deeper insights that will help guide the integration of 2D materials as active
components of electronic devices for direct-read, affordable DNA sequencing. This award will strengthen the
research environment at the University of Central Oklahoma and engage students in computational research.
Our research plan has specifically been designed to optimize the utilization of students with diverse background
and interests.

Public health relevance
Relevance to Public Health The ability to detect and discriminate DNA bases by reading it directly using simple and cost-effective methods is an important problem whose solution can produce significant value for areas such as cancer and human genetic disorders. This research will evaluate the potential of several two-dimensional materials beyond graphene (including van der Waals heterostructures) for DNA sequencing based on electronic methods. The knowledge gained will provide deeper insights that will help guide the integration of these materials as active components of electronic devices for fast, direct-read, and affordable DNA sequencing.